5mC and 5hmC DNA alterations as sensitive and specific biomarkers for the non-invasive early detection of pancreatic ductal adenocarcinoma

Project Summary: Pancreatic ductal adenocarcinoma (PDAC) is a highly aggressive malignancy and is rapidly
becoming the 2nd leading cause of cancer-related deaths. The dismal 5-year survival rate of ~10% (the lowest
of any major cancer) essentially stems from the fact that PDAC is diagnosed at late stages. Achieving early
detection is crucial, offering a pivotal shift in staging that holds the promise of improved survival rates. Previous
attempts to develop PDAC early detection tests have suffered from flaws in their study design, including 1) failure
to enroll early-stage PDAC cases, 2) assuming that a biomarker developed in metastatic settings would also
detect early-stage PDAC, or 3) assuming that a tissue-derived biomarker would also function in the blood.
Therefore, we will develop and validate a bloodborne test in a cohort of patients enriched for early-stage PDAC.
We will use the PLCO population to evaluate the lead time to PDAC diagnosis on pre-diagnosis biospecimens.
Our test will be minimally invasive, highly sensitive, and cost-effective by harnessing the potential of 5-
methylcytosine (5mC) and 5-hydroxy methylcytosine (5hmC) modifications on circulating cell-free DNA.
Importantly, commercially available tests based on 5mC demonstrated a high sensitivity for PDAC while a 5hmC-
based test demonstrated specificity (but suboptimal sensitivity). Because 5hmC modifications occur genome-
wide and are abundant, they are biologically sensitive biomarkers, while 5hmC modifications are typically gene-
targeted and display >90% cancer- and stage-specificity. Therefore, a combination of the two approaches, one
contributing sensitivity (5mC) and the other contributing specificity (5hmC) is desirable, innovative, and
necessary to optimize the early detection of PDAC. Our goal is to develop a robust assay for detecting early-
stage PDAC. Our design strategy will involve three aims. First, we will discover aberrantly methylated loci
potentially diagnostic for PDAC with 5mC- and 5hmC-profiling in circulating cfDNA and matching tissues.
Second, we will develop 5mC and 5hmC-based diagnostic biomarker signatures that discriminate patients with
PDAC from controls using multiple advanced machine learning and statistical approaches. Here, we will train
two machine learning algorithms—one for 5mC and another for 5hmC—to identify patients with PDAC based on
qPCR results and then merge these two algorithms to create a detection signature for PDAC. Then, we will
validate the 5mC, 5hmC, and 5mC+hmC qPCR assays in a large, cross-sectional cohort of biobanked samples
from patients with PDAC vs. controls. Third, we will perform the 5mC, 5hmC, and 5mC+5hmC qPCR assays in
prospectively collected samples from the PLCO study to determine how our assays may provide a positive PDAC
signal much earlier than clinical diagnosis. In summary, this project aims to develop a highly sensitive, cost-
effective liquid biopsy for early detection of PDAC. If successful, this proposal will involve several innovations
and will have the potential to transform clinical practice.

Public health relevance
NARRATIVE: We will perform a comprehensive and genome-wide evaluation of cell-free DNA methylation biomarkers in blood samples as potential noninvasive biomarkers for the early detection of pancreatic cancers. Moreover, we will gauge the potential for anticipating the diagnosis in clinical samples collected before PDAC clinical diagnosis during the PLCO Trial. Successful identification of such biomarkers will provide a major advance in the management of this fatal disease.